The Integration and Implementation of FDA's Produce Safety Rule and The Commonwealth Quality Program

Project Summary Project Title: The Integration and Implementation of FDA’s Produce Safety Rule and the Commonwealth Quality Program (CQP) Project Description: The Massachusetts Department of Agricultural Resources (MDAR) intends to continue its current voluntary farm food safety program in Massachusetts, and integrate FDA’s Produce Safety Rule, into a comprehensive and scalable produce safety program in Massachusetts. We intend to develop a strategic plan to implement this initiative in full compliance with FSMA’s Produce Safety Rule. This strategic plan will include education and training for produce farmers covered under the rule, as well as implementation of a regulatory and operational framework in support of the state program. Project Goals: The proposed project will develop a strategic plan for alignment of MDAR’s existing regulations, programs and activities with FDA’s Produce Safety Rule. Goals include establishing an inventory of covered produce farms, benchmarking current program operations and procedures alongside proposed initiatives, developing an educational plan for the continued provision of training on the state’s produce safety program and the Produce Safety Rule for farmers, completing an assessment of MDARs regulatory authority for produce safety and the resources needed to develop a successful program, and implement the program. Expected Outcomes: It is our intent that the work outlined in this proposal will create a federal-state relationship which will leverage the existing expertise, knowledge and resources of the Massachusetts Department of Agricultural Resources resulting in the continued and consistent delivery of a state produce safety program as envisioned by MDAR and the FDA. Project Objectives: 1) Develop, integrate and maintain an inventory (database) of produce farms covered under the rule, including a mechanism to share the data with the FDA. 2) Determine and assess the resources needed to conduct activities under a state produce safety program, that has been aligned with FDA’s Produce Safety Rule (identify metrics & develop and deploy plans for the training, technical support/assistance for covered farms, identify develop and deploy information technology, sampling and laboratory capabilities, & inspection/compliance activities). 3) Develop and implement a five year strategic plan that includes educating producers on produce safety and providing regulatory oversight for covered produce in Massachusetts. The plan will include program administration and operations, on-farm inspections and audits, environmental and product sampling, compliance and enforcement, training, education and technical assistance. Budget: $499,916 for year one, $717,262 for year two, $747,775 for year three, $762,447 for year four and $852,248 year for five, totaling $3,579,649 for the five year grant period.

Public health relevance
Project Narrative Project Title: The Integration and Implementation of FDA’s Produce Safety Rule and the Commonwealth Quality Program (CQP) This Massachusetts Department of Agricultural resources project, entitled The Integration and Implementation of FDA’s Produce Safety Rule and the Commonwealth Quality Program (CQP) is intended to continue the produce safety program in Massachusetts that will continue to encourage the safe production of fruits and vegetables and promote understanding and compliance with the FDA’s Produce Safety Rule. To integrate the Department’s existing produce safety program with the produce rule into a new model produce safety program in Massachusetts, MDAR will:  Obtain and evaluate information on current state requirements applicable to produce on farms and review existing statutes to conduct on-farm inspections, conduct surveys and outreach, perform training to internal resources and strategic partners across the Commonwealth, provide education and technical assistance, and take enforcement action when necessary for compliance with on-farm produce safety requirements within a fully integrated produce safety program in Massachusetts.  Develop and assess information on the resources needed by MDAR to conduct these activities as part of their implementation of state produce safety program that is fully aligned with FDA’s produce safety rule,  Develop a strategic plan, that includes goals and milestones, for the integration and further development and enhancement of the MDARs existing produce safety program CQP, and through such exercise, design and implement a comprehensive state produce safety program, fully aligned with the Produce Safety Rule, and  Identify the resources, partnerships and tactical plans needed for the successful implementation of the program, and  Utilize the strategic plan to implement a produce safety program. These five goals will advance a state produce safety program that is scalable and will provide broad educational, inspection and audit support in contribution to a nationally integrated food safety system (IFSS) and fulfill the requirements of the Food Safety Modernization Act (FSMA) and provide market access for produce farms in Massachusetts.